The role of injection partnerships and preferences for reducing HCV risk: Giving a voice to young women in rural Appalachia

PROJECT SUMMARY
The purpose of this K01 Mentored Research Scientist Development application is to develop Dr. Kathryn
Lancaster's career as an independent investigator in conducting long-term, meaningful research at the
intersection of substance use and blood-borne infections among women. This K01 will provide Dr. Lancaster
with the necessary support to extend her skills to truly transformative and important new directions in 1)
multilevel data collection and analyses, 2) biological and clinical aspects of hepatitis C virus (HCV) acquisition
and disease progression, 3) stated-preference theory and application of discrete choice experiments, and 4)
building capacity for community-academic partnerships for addressing injection drug use in a new
sociocultural environment— rural Appalachia. In support of these skills, Dr. Lancaster is supported by an
outstanding interdisciplinary team of mentors with robust research portfolios, successful mentorship histories,
and a strong track record of collaboration. This team includes: Dr. Christopher Browning (Primary Mentor), Dr.
Carlos Malvestutto (Co-Mentor), Dr. John F P Bridges (Co-Mentor), and Dr. April Young (Co-Mentor).
Injection drug use and HCV among young women is dramatically rising in rural settings within the United
States. HCV risks and utilization of harm reduction services, like syringe service programs (SSP), within each
injection partnership vary due to complex cultural and gender norms. The social milieu that impact young
women who inject drugs (YWID) requires an in-depth understanding of how partnership-level factors and
preferences for SSP shape HCV risk reduction in rural settings. The goal of this study understand the role of
injection partnership-level factors on HCV risk and measure preferences for SSP among YWID in rural
Appalachian Ohio (Scioto, Pike, and Jackson Counties). Dr. Lancaster will leverage the NIDA-funded National
Rural Opioid Initiative (UG3) study infrastructure and community-academic partnerships to specifically: 1)
Describe the contribution of injection partnership-level factors on HCV risk behaviors among YWID in rural
Appalachia; 2) Determine the effect of injection partnership-level factors on HCV risk behaviors among YWID
in rural Appalachia; and 3) Elicit preferences for SSP among YWID in rural Appalachia. In-depth interviews
with YWID will be conducted to explore the how HCV risk behaviors may vary within and across injection
partnerships. Intensive granular, temporal data data will be collected quarterly using in-person behavioral
surveys and augmented with monthly ecological momentary assessments to capture injection partnership-level
factors and HCV risk behaviors in real-time. A formal elicitation of stated preferences for SSP will illuminate
attributes for services tailored for YWID. The training and research plan will produce preliminary data to inform
a NIDA R01 application to conduct a multisite, randomized controlled trial evaluating the effectiveness of a
tailored harm reduction package, addressing injection partnership factors that will reduce HCV risk among
YWID rural Appalachian.

Public health relevance
PROJECT NARRATIVE Hepatitis C virus is dramatically rising in rural Appalachia, placing young women who inject drugs at risk within their injection partnerships. Using a mixed methods approach, the proposed project will 1) examine factors within injection partnerships that influence HCV risk and 2) measure preferences for obtaining services that reduce HCV risk among young women who inject drugs. The proposed training will enhance the skills needed for the applicant to become an independent investigator capable of securing R01 funding from NIDA and making a significant contribution to the field of substance use and blood-borne infections among women in underserved areas.